Cell Based Immunomodulation to Promote Post-Infarct Myocardial Repair

PROJECT SUMMARY
Ischemic heart disease is the leading cause of death in the industrialized world. Heart failure (HF) develops in
20-30% of patients after myocardial infarction (MI) due to extensive scarring exacerbated by a persistent 2.9-
fold increase of inflammatory macrophages in the infarct borderzone and remote myocardium. Cytokines, such
as Interleukin-10 (IL-10), and cytokine inhibitors, such as Interleukin-1 receptor antagonists (IL-1Ra), are potent
immune modulators that regulate inflammation, reduce infarct size, and improve ventricular function. However,
translation of cytokine therapy to patients has been limited by poor biodistribution, toxicity, and paradoxical pro-
inflammatory responses with sustained administration. Local immunomodulation with cell therapy secretion of
cytokines holds promise, but poor cell survival (<1%) and reduced in vivo potency have remained critical barriers
preventing clinical translation. We have overcome these critical limitations by developing an innovative and
translational cell therapy platform that enables sustained locally administration to the heart after MI. We have
engineered retinal pigment epithelial (RPE) cells to produce IL-1Ra and IL-10 in a more physiologically relevant
paracrine fashion at high local concentrations without systemic absorption and have encapsulated them in
alginate-based core-shell capsules, shielding them from the host immune system and allowing them to serve as
a regulatable in situ cytokine “factories”. We have demonstrated that local delivery modulates inflammation and
improves outcomes after acute MI. In this proposal, we hypothesize that epicardial implantation of RPE-IL10 and
RPE-IL1Ra will sustain reductions in post-MI chronic inflammation and reverse cardiomyopathic remodeling in
HF. In Aim 1, RPE cell capsule systems will be developed and optimized for sustained 6 month secretion of IL-
10 and IL-1Ra with integration of an apoptotic cell safety switch to cease therapy post-administration. In Aim 2,
these IL-10 and IL-1Ra cytokine factories will be validated as mono- or combination therapies in a chronic post-
MI rat HF model by confirming reduction of the cardiac inflammasome, promotion of reparative macrophage
phenotypes, and reversal of adverse cardiac remodeling. In Aim 3, the ability to titrate and cease therapy post-
implantation in a clinically relevant fashion will be evaluated in a porcine model. Efficacy of RPE therapy will be
tested in a chronic porcine infarct model over 100 days. The proposed work is expected to result in a new immune
modulatory strategy for MI and elucidate mechanisms of cytokine therapy on the cardiac inflammasome.
Importantly, the developed biotechnology will be ready for pre-clinical testing and has translational benefit
beyond cytokines alone, as it can be utilized for a wide range of protein and local drug delivery directly to the
heart.

Public health relevance
PROJECT NARATIVE Decreasing inflammation in the heart after heart attack (myocardial infarction) has shown promise at improving heart function and reducing adverse cardiovascular events in patients with heart failure. While systemic immunomodulation has shown promise to reduce myocardial inflammation and promote tissue healing, the efficacy of this potentially transformative approach remains limited by inefficient delivery to heart, off-target effects, and pleiotropic and sometimes paradoxical responses that prevents application for chronic heart failure. This project will address these shortcomings by utilizing a novel cell therapy platform to (i) enable sustained cell survival and delivery of secretory proteins to the heart, (ii) understand how this changes heart immune populations to promote heart tissue repair, and (iii) translate therapy in a clinically relevant fashion to a large animal model of heart failure.